Developing and Determining Feasibility of a Novel Upper Extremity Robotic Exoskeleton to Track and Target Unwanted Joint Synergies during Repetitive Task Training in Stroke Survivors

Stroke causes significant long-term disability and the incidence of stroke in our Veteran population is high with
approximately 6,000 VA admissions for acute ischemic stroke per year in 2014. Rehabilitation programs that
improve upper extremity function have the potential to impact Veterans’ activities of daily living and improve their
vocation, recreation, and overall quality of life. Repetitive task training (RTT) is active practice of a task-specific
motor activity and is more effective than simple joint movements in improving upper extremity function after
treatment. However, RTT can be draining for both the clinician and the patient as it requires the participant to
complete many repetitions of the same task and those repetitions can be difficult to accomplish with appropriate
technique. Previous research has shown that to significantly affect patient recovery it is critical to initiate RTT in
the acute and sub-acute stages, maintain health joint coordination, and keep the patients engaged and challenged.
Robot-mediated RTT has the potential to facilitate the clinical delivery of proven rehabilitation programs to our
Veterans in need and recently a new exoskeleton has been developed, called Harmony, with the ability to deliver
bimanual 3D arm therapy. Currently there a lack of tools for delivering RTT in the early stages of recovery while
maintaining joint coordination during 3D arm movement and ensuring that assistance commensurate with patient
abilities. Therefore, the objective of this project is to develop novel controllers that use promising neurological basis
for training to facilitate repetitive task training while ensuring correct movement patterns in acute and sub-acute
stage stroke patients. Specifically, (1) synergy avoidance (SA) controller will apply joint torques to push the
patients away from the maladaptive joint coordination, only interfering with the movements once the subject
initiates such a maladaptive movement strategy. (2) Task assistance (TA) controller will apply assistive joint
torques to directly help stroke patients achieve 3D RTT activities with correct coordination at a high intensity
(repetitions/session). Aim 1: to develop and determine feasibility of RTT controller. H1: SA and TA controllers are
feasible, as seen by (1) patient safety and (2) abilities of TA and SA controllers to move upper-body joints along
task trajectories and away from synergistic coordination, respectively. Up to five sub-acute stroke survivors will
complete RTT activities with both the SA and TA controllers. H1 will be considered supported if the applied torque
meets the requirements defined by the control law and the feasibility criteria are met for the TA and SA controllers
in two consecutive patients. Aim 2: determine feasibility of controllers and quantify change in joint coordination
during 3-week intervention. H2a: a 3-week long intervention is feasible with both the controllers as seen by (1)
patient safety and (2) abilities for TA and SA controllers to move the upper-body joints toward the desired
trajectories for 3D RTT activities while avoiding synergistic compensatory coordination. H2b: the robotic system
will accurately track joint synergies in acute stroke patients before and after a 3-week intervention, revealing any
change in compensatory strategies. Two acute stroke survivors will be recruited. Participants will be assigned to
either the TA or SA controller and will complete high repetitions of reaching tasks once per day while wearing the
Harmony exoskeleton for three weeks. Joint kinematic and kinetic data will be recorded by the robotic system in
all the sessions. Kinematic data will also be recorded in the evaluation sessions before and after the 3-week
intervention in two modalities: robot in zero-torque mode and using an infrared motion tracking system. Joint
synergies will be evaluated for the two acute stroke patients before and after a three-week intervention.
Hypotheses will be considered supported if there is an acceptably low rate of error between the kinematic
measurements of the robotic system and the motion capture system. New rehabilitation programs that improve
upper extremity functional performance have the potential to impact Veterans’ ADL and improve their vocation,
recreation, and overall quality of life. New rehabilitation programs that improve upper extremity function have the
potential to impact Veterans’ ADLs and improve their vocation, recreation, and overall quality of life.

Public health relevance
Stroke is the leading cause of adult-onset disability, and affects 15,000 Veterans each year. Successful rehabilitation and recovery following a stroke requires therapy including repetitive task training. However, repetitive task training can be draining for both the clinician and the patient as it requires the participant to complete many repetitions of the same task and those repetitions can be difficult to accomplish with appropriate technique. Robot-mediated repetitive task training has the potential to facilitate the clinical delivery of proven rehabilitation programs to our Veterans in need and recently a new exoskeleton has been developed, called Harmony, which can deliver bimanual 3D arm therapy. We propose to develop and test two novel controllers’, synergy avoidance and task assistance, that use promising neurological basis for training to facilitate repetitive task training while ensuring correct movement patterns in acute and sub-acute stage stroke patients. This has the potential to improve Veterans’ activities of daily living and quality of life.